RETT SYNDROME-- CLINICAL NEUROPHYSIOLOGY

This protocol examines pathophysiologic mechanisms related to Rett Syndrome. It seeks to identify a specific marker and to provide evidence that links Rett Syndrome to an X-chromosome abnormality related to non-random inactivation. (Days are with Protocol 426.)